Exploring the role of Oligodendrocytes and progenitors on chronic brain implants

Project Summary This R21 (PA-16-161) application aims to greatly improve basic science understanding of oligodendrocytes and oligodendrocyte progenitor cells with respect to spatial and temporal dynamic changes around chronically implanted microelectrodes and long-term recording performance. Penetrating recording microelectrode arrays are a crucial component of numerous human neuroprosthetics. Obtaining selective, high fidelity, long-lasting readouts of brain activity is a critical technology across basic and applied neuroscience that impacts learning and memory studies as well as motor, pre-motor, and visual cortex neuroprostheses and brain-computer interfaces. However, implantation of cortical microelectrodes causes a reactive tissue response, which results in a degradation of the preferred functional single-unit performance over time, thus limiting the device capabilities. While the BBB and the role of other glial cells like microglia and astrocytes have long been studied with respect to the degradation of chronic recording performance, the role of oligodendrocytes and oligodendrocyte progenitor in this foreign body response has been understudied. This proposal aims to characterize the role of oligodendrocytes and oligodendrocyte progenitor cells and chronic recording failure in vivo caused by the insertion via quantifying structural, cellular, and molecular level tissue response to chronic implants in the brain in real time through combining multiphoton imaging technology and neural engineering technology at the University of Pittsburgh. A dynamic understanding of the interfaces is necessary for elucidating the mechanism(s) behind neural recording failure. Oligodendrocytes and oligodendrocyte progenitor cells have been implicated as key players in neuronal health following brain injury and numerous neurodegenerative diseases. Therefore, this work has the potential to output basic and clinical science level knowledge relevant to neural engineering, ischemia, stroke, intracortical hemorrhage, aneurysm, traumatic brain injury, and closed-loop neurostimulation.

Public health relevance
Project Narrative Oligodendrocytes and oligodendrocyte progenitor cell play an important role in a number of brain injury and neurological diseases. This proposal details an innovative in vivo imaging technology that will explore how these cell types cause negative tissue response to neural probes and therefore improve future probe designs.